Consumer Responses to Modified Risk Tobacco Product Claims

Project Summary/Abstract Cigarette smoking is the leading cause of preventable death and disease in the US, and is responsible for nearly one-­third of all cancer deaths. To help reduce these harms, the Family Smoking Prevention and Tobacco Control Act granted FDA broad regulatory authority over tobacco products, and included a structured process for the marketing of reduced-­risk tobacco products, called modified risk tobacco products (MRTPs). FDA can authorize MRTP marketing if evidence demonstrates that doing so will reduce harm and risk of tobacco-­related disease to individual users and benefit population health. Two types of MRTP claims can be authorized by FDA: 1) risk modification (reduced risk of tobacco-­related diseases), 2) exposure modification (reduced exposure to harmful chemicals). Further, MRTP claims can be classified by specificity. For instance, claims can be general (e.g., reduced-­risk of tobacco-­related diseases) or specific (e.g., reduced-­risk of heart disease). To date, no MRTP claims have been authorized by FDA, and the public health impact of MRTP marketing remains unknown. The harm reduction potential of MRTP claims will depend on patterns of MRTP use. For instance, cigarette smokers could potentially benefit by switching completely to an MRTP. However, harm may increase if MRTP claims cause non-­smokers to initiate MRTP use. Further, cessation from cigarettes could be undermined if smokers initiate MRTP use and continue smoking (i.e., dual product use). Therefore, knowledge of how consumers respond to MRTP claims is essential to FDA regulatory actions. The proposed research utilizes a multi-­method approach to advance understanding of consumer responses to MRTP claims. The specific aims of the proposal are: 1) Conduct a systematic review of published research on consumer responses to MRTP claims;? 2) Analyze nationally-­representative survey data (i.e., 2017 HINTS-­ FDA) to estimate the prevalence and predictors (e.g., sociodemographic, tobacco use behaviors) of interest in using MRTPs;? 3) Conduct an online experiment to determine whether the relationships between exposure to MRTP claims and MRTP use intentions and cigarette quit intentions vary by MRTP claim type (i.e., exposure vs. risk) and MRTP claim specificity (i.e., general vs. specific). The research proposal will support the applicant’s continued training in tobacco control, health communication, and ethical conduct of research, and will help the applicant achieve his goal of becoming an independent cancer prevention researcher. More importantly, the proposed study will help inform FDA regulation of MRTP claims, and directly responds to immediate research needs identified by FDA’s Center for Tobacco Products. The data collected from the proposed study could help FDA maximize potential benefits and minimize unintended consequences associated with MRTP claims.

Public health relevance
PROJECT NARRATIVE FDA can authorize the marketing of tobacco products with modified risk tobacco product (MRTP) claims, which could encourage smokers to completely switch to a less harmful tobacco product;; or possibly cause harm by promoting tobacco use among non- smokers or dual product use (i.e., cigarette and MRTP use) among smokers. Using a multi- method approach, the proposed research will assess responses to MRTP claims. Findings from this study could help inform FDA regulatory decisions, and help to maximize potential health gains and minimize unintended consequences associated with MRTP claims.